Characterizing the impacts of a novel environmental contributor on ROS hormesis and aging in C. elegans

Project Summary/Abstract
As the average age of the global population continues to rise, finding strategies to promote not only longevity,
but healthspan, is critical. For example, aging is a major factor in the development and progression of many
neurological disorders, and it increases the financial burden on healthcare systems, presenting new challenges
within our society for caregiving and emotional wellbeing. In this regard, there is much interest in determining
whether healthy aging can be enhanced. Our lab has identified an environmental factor that has a hormetic
effect on both lifespan and neurodegeneration in the nematode model organism, Caenorhabditis elegans
(C. elegans). When nematodes are chronically exposed to higher concentrations (20X) of this environmental
factor, they have shorter lifespans and exhibit neurodegeneration of dopaminergic neurons. Conversely, when
chronically exposed to low concentrations (5X), they live longer and do not display neurodegeneration. The
factor we discovered is a secreted metabolite produced by the common soil bacterium Streptomyces
venezuelae (S. ven). Similar to many substances that display hormetic responses, I have determined that this
metabolite functions via the transcription factor DAF-16/FOXO. This transcription factor regulates longevity
through the activation or repression of signaling molecules associated with oxidative stress responses. In this
proposal, I will utilize C. elegans to further investigate the differences in the aging process following exposure
to high (20X) and low (5X) concentrations of the S. ven metabolite. Aim 1 seeks to investigate hormetic ROS
induction following exposure to different concentrations of S. ven metabolite. This will be addressed via a)
Quantifying cellular alterations by examining differences in ROS levels using in vivo and ex vivo assays and b)
Investigating the impact of S. ven metabolite on ATP levels. I hypothesize 5X S. ven metabolite will cause mild
ROS induction that is beneficial to C. elegans, while 20X will do the opposite. In Aim 2, I will examine a DAF-
16-dependent longevity response. The mechanism underlying the hormetic response will be sought using
aging analyses and qPCR on differentially expressed genes (DEGs) from a prior transcriptomic analysis. I
previously identified 20 DEGs associated with daf-16 and/or daf-2; of which several are associated with
oxidoreductase processes that I am interested in further pursuing. I hypothesize that the hormetic response is
impacting the insulin/IGF-1 signaling pathway to confer the extended lifespan phenotype observed when
worms are exposed to 5X metabolite. I also propose that the metabolite is altering the expression of DAF-16-
dependent genes, particularly DEGs involved in oxidoreduction processes thus impacting longevity. Ultimately,
defining a molecular signature of this hormetin will illustrate signaling pathways influenced by a previously
identified neurotoxin, and could provide a promising approach for the identification of treatment targets for age-
related disorders.

Public health relevance
Project Narrative As the average age of the global population continues to rise, identifying factors that either accelerate or delay the aging process is imperative for understanding how to combat age-related disorders. Compounds that induce the production of reactive oxygen species (ROS) have been found to cause a phenomenon known as ROS hormesis, where mild levels of ROS appear to be beneficial to organismal health and longevity. This proposal aims to investigate the impacts of a novel environmental contributor that impacts aging and causes increased ROS production in C. elegans, through characterization of specific gene classes; thus, providing further insight into candidate targets and pathways that could impart a more thorough understanding of causes of aging at the molecular level.